2/3 Genomics of Schizophrenia in the South African Xhosa

Contact PD/PI: Susser, Ezra S.
PROJECT DESCRIPTION
The goal of this international collaborative project, in response to PAR-20-027, is to characterize the genetic
architecture of schizophrenia in the Xhosa population of South Africa. The three participating sites have
already successfully established the infrastructure necessary to undertake the aims of this proposal: University
of Washington, Seattle (Mary-Claire King, Jack McClellan, Tom Walsh, MPIs); Columbia University, New York
(Ezra Susser, PI); and University of Cape Town, South Africa (Dan Stein, PI).
African populations harbor far more genetic variation than out-of-Africa populations, facilitating discovery of
associations between genotypes and phenotypes. Our initial study (Gulsuner at al., Science, 2020) was the
first large-scale genetic study of schizophrenia in an ancestral African population. We discovered that Xhosa
individuals with schizophrenia (cases) are enriched for rare damaging mutations in genes intolerant to such
mutations. The effect was particularly strong for damaging mutations in genes involved in synaptic functioning.
These results extend understanding of schizophrenia genetics, specifically supporting an oligogenic, severe
alleles model and a role for rare damaging mutations in genes critical to synaptic signaling and plasticity.
For this project, we propose to enroll an additional 1250 cases and 1250 age- and gender-matched controls, all
Xhosa-speaking, bringing our total study population to 5425 participants. We will apply new genomic
technology to identify previously undetectable classes of mutations likely to be implicated in schizophrenia. The
genomic structure of Xhosa cases and controls will be characterized using whole genome sequencing (wgs),
both short–read Illumina wgs to identify conventional classes of mutations and long-read PacBio wgs to identify
structural variants of all types, mobile transposable elements, and repeat expansions. In addition, SAX v2, the
African-variation-enriched SNP array developed for this project by Affymetrix, will be used to identify copy
number variants (CNVs).
Africa is the single most informative continent for understanding the human genome and human disorders with
worldwide impact. African populations provide the most complete human reference genomes for screening
candidate risk alleles for any phenotype. The whole-genome sequencing strategies used in this project allow
the comparison of all classes of damaging mutations between cases and controls, including the detection of
case-specific copy number variation and repeat expansions, while also providing a resource for human
genomics research worldwide.
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: Susser, Ezra S. PROJECT NARRATIVE Africa, the birthplace of modern humans, is the single most informative continent for understanding the human genome and human disorders with worldwide impact. Since most genomic research has not involved African populations, generations of human genetic history are missing from our understanding of human genetics and complex disease. In this study, we will use novel whole genome sequencing strategies to characterize the genetic bases of schizophrenia in the Xhosa population of South Africa. Project Narrative Page 7